Commercialization Readiness Pilot Program support for: HATS-OFF

7. PROJECT SUMMARY/ABSTRACT
Heart Failure (HF) effects 6 million Americans resulting in more than 1 million annual hospitalizations, over
25% re-hospitalizations and $20 billion in cost of care and higher. The standard recommended practice of
monitoring weights and symptoms has not demonstrated reduction in hospitalizations. Thus, given the clinical
and economic impact of HF hospitalizations, there is a need for a non-continuous, non-invasive, easy-to-use-
at-home method for long-term monitoring to detect HF decompensation early and therapy intervention to avoid
hospitalization. The R&D and clinical trial funded by the parent SBIR Phase II grant (1R44HL145941) has
developed the needed non-invasive heart failure hemodynamic monitoring technology, called, HEMOTAGÒ
HATS-OFF (Hemotag AssessmenT for Short-term Outcomes oF heart Failure) that provides accurate,
absolute, and actionable hemodynamic measurements, enabling the monitoring of fluid congestion in a heart
failure patient at home. Clinical results from the Phase II surpassed our milestones, in addition the randomized
clinical trial demonstrated statistically and clinically significant reduction in hospitalizations. Along with very
strong commercial engagements with our clinical partners, demonstrate the success of the Phase II. While our
phase II grant resulted in a safe and functional product, critical funding gap remains before the device can
achieve commercialization. Specifically, we must: lower manufacturing cost, based on recognition of a need to
install a larger number of systems at home; enable electrocardiogram (ECG) functionality needed to monitor
rhythm related heart failure events; and perform all activities necessary for FDA 510(k) clearance with the
desired clinical indication of use. In this work we propose three major task areas for this late-stage
development project: 1) To manufacture the HATS-OFF device with ECG functionality and HF monitoring
capabilities resulting in a simple, reliable, and cost-effective device configuration for longer-term home use. 2)
Finalize and implement a quality system to bring the development process under design and quality systems
control. Optimization of device manufacturing necessary to ensure consistent and scale-up manufacturing
according to recognized quality standards and in compliance with expected good manufacturing practices
(GMPs) and applicable FDA requirements, including measures and activities to control manufacturing of
upstream and downstream processes, in-process sampling, testing, process validation and related production
requirements. 3) Regulatory Assistance to include strategy, documentation, submission of 510(k) application to
the Food and Drug Administration (FDA). This will greatly enhance our ability to obtain additional funding and
strategic partnerships. Successful completion of the proposed aims will result in a new technology to allow
rapid, accurate and frequent surveillance of HF to maximize quality of life and prevent hospitalizations. After
HATS-OFF is approved for HF monitoring, and with commercial scale manufacturing in place, our plan is to
raise additional capital to build a sales force and launch the product.

Public health relevance
8. PROJECT NARRATIVE This Commercialization Readiness Program, CRP, (SB1) proposal is directed towards the commercialization of the HEMOTAG HATS-OFF product as funded by the parent SBIR Phase II grant (NHLBI Phase II SBIR, 1R44HL145941-01A1). This CRP will fund finalization of the Quality system to support commercialization and scale-up manufacturing suitable for initial product launch as well as the finalization of regulatory strategy to yield commercially viable label claims for HEMOTAG HATS- OFF guided treatment for heart failure patients.